The DF phospho-code regulating the degradation of m6A mRNA

PROJECT SUMMARY:
N6-methyladenosine (m6A), the most abundant nucleotide modification in the transcriptome, has the well-
established function of causing instability of modified mRNAs. Importantly, differentiation of hematopoietic stem
cells is one of the most-well studied scenarios in which m6A-modified mRNAs appears to be preferentially
degraded. Although this degradation process appears to be a highly regulated event to ensure cellular
commitment, a clear mechanism of how this event is regulated is missing.
My recent work demonstrated that the major mediators of m6A-mRNA degradation are the YTHDF (DF)
proteins. Thus, a major goal is to understand how these proteins are regulated to trigger m6A mRNA
degradation. My working hypothesis, which is supported by preliminary data, is the existence of a specific DF
phosphorylation-code regulating the DF ability to degrade m6A-mRNA. In this proposal, I will map this DF
phospho-code, identify the DF targeting kinases, and determine how DF phosphorylation affects the
differentiation of hematopoietic stem cells. Overall this proposal may reveal how DF phosphorylation controls
m6A mRNA stability and its fundamental role during the differentiation commitment of the hematopoietic stem
cells.

Public health relevance
PROJECT NARRATIVE: Three redundant proteins, the YTHDF proteins, share the unique function to degrade mRNAs marked with a specific chemical modification called m6A. However, it’s been challenging understanding how this process is regulated. Using innovative technologies, I propose to study how these YTHDF proteins are dynamically regulated to control the degradation of m6A-marked mRNAs and the impact of this mechanism in hematopoietic stem cells differentiation.